Novel Coregulators of Estrogen Receptor in Enhancer-regulated Transcription

Novel Coregulators of Estrogen Receptor in Enhancer-regulated Transcription Estrogen (E2 or 17b-estradiol) and its nuclear receptor ERα are critical for the normal development and disease conditions of multiple organs, including mammary glands. E2 and ERα regulate transcriptional programs in these biological contexts through binding primarily at distal enhancers. Increasing evidence indicates that functional dysregulation of ERα-bound enhancers profoundly alters normal transcriptional programs, leading to developmental defects, diseases, and hormone resistance. However, the molecular mechanisms underlying the enhancer function/dysfunction are largely unknown. My lab has been focusing on studying two key questions on ERα-bound enhancers: 1) how are estrogen-regulated enhancers assembled under different conditions? 2) how do the enhancer components encode the context-specific function of each individual enhancer in vivo? Using a powerful proximity proteomics approach, we recently identified additional ERα-interacting coregulators including YAP/TEAD, two key components of Hippo pathway to mediate nuclear effects. Our preliminary data suggest YAP/TEAD function in a non-canonical manner to interact with ERα on ERα-bound enhancers and play a key role in ERα-mediated transcriptional programs under normal signaling condition or during the development of hormone resistance . In this grant proposal, we are proposing two specific aims to test the hypothesis that YAP/TEAD are important
novel coregulators required for the activation of ERα-bound enhancers, and the cooperative interactions between YAP/TEAD and ERα control the context-specific function of ERα-bound enhancers in vivo through enhancer reprogramming. The proposed work will provide a mechanistic interpretation on how YAP/TEAD and ERα signaling crosstalk at the chromatin level and converge on enhancers to control downstream gene expression under different conditions, and lay the foundation for future development of improved ER-targeted therapy.

Public health relevance
Estrogen-regulated transcriptional programs are essential for normal development and disease conditions of multiple organs, including mammary glands, and these programs are tightly regulated by the binding of estrogen receptor with DNA regulatory elements, specially enhancers. However, the molecular details of how estrogen-regulated enhancers are assembled and how the enhancer components control the distinct function of each individual enhancer in vivo are lacking. In this grant, we are focusing on two newly identified ERα coregulators YAP and TEAD, and aim to study their roles in regulating the assembly and function of ERα-bound enhancers. The knowledge gained will increase our ability to understand enhancer function mechanisms and provide insights for future development of improved ER-targeted therapy.